Peripheral and central nervous system inflammation associated with military sexual trauma and PTSD

Military sexual trauma (MST) is unfortunately common in Veterans, particularly in women, and has life-
long consequences for physical and mental health. MST, which includes both sexual assault and harassment,
is strongly associated with post-traumatic stress disorder (PTSD) and co-morbid conditions including,
depression, anxiety, substance use, obesity and eating disorders, chronic pain, and autoimmunity. While other
psychiatric conditions, including depression and anxiety, are associated with inflammation, PTSD is uniquely
associated with a >50% increase in autoimmune disorder prevalence (e.g., rheumatoid arthritis, thyroiditis, and
inflammatory bowel disease). Exposure to MST further increases the risk of developing an autoimmune
disorder by over two-fold. Although increased peripheral inflammation is well characterized in PTSD, it is
unclear if peripheral inflammation reflects a disruption in immune signaling in the central nervous system
(CNS). Moreover, phenotyping the immune dysregulation that occurs with PTSD has almost exclusively
occurred through cross-sectional data collection. However, without longitudinal studies that track immune
biomarkers in conjunction with symptoms, it is unknown if immune biomarkers have clinical utility in guiding
treatment. Furthermore, while epidemiological data support that trauma disorders, particularly MST, may have
shared risk factors with autoimmune disorders, it is unknown if MST confers unique effects on immune
signaling. Filling these gaps is critical to understanding if and how immune dysregulation contributes to
symptom "state" in Veterans with MST to inform its viability as a potential mechanism for targeted treatment.
This proposal will address these knowledge gaps by quantifying circulating inflammatory cytokines in
Veterans with MST-related PTSD (+MST/+PTSD) and comparing cytokine levels to Veterans without PTSD or
MST. In addition to examining circulating plasma cytokines, we will also measure cytokines and miRNA
isolated from and astrocyte-derived exosomes (ADEs), which are extracellular vesicles that carry RNA and
protein cargo to the blood from the CNS. Measuring biomarkers from exosome populations derived from CNS-
tissue sources can non-invasively assess neuroinflammation and compare peripheral vs. central inflammation
links to PTSD symptoms. We hypothesize that levels of baseline peripheral (plasma) and central (exosome)
inflammatory markers will be altered in female Veterans with +MST/+PTSD compared to female Veterans
without MST or PTSD. Based on the existing literature of psychoneuroimmunologic correlates of PTSD, we will
quantify IL-1β, IL-2, IL-6, IFNγ, and TNFα cytokines from both plasma and exosome cargo using multiplex
arrays. We will also quantify immune regulatory miRNA from exosome cargo. In the +MST/+PTSD group, we
will also collect plasma samples at 3- and 6-month follow-up visits to determine if inflammatory biomarkers are
associated with symptom trajectory across time. A highly stable marker that does not track with symptoms
would suggest it is a marker of risk. In contrast, if a marker changes alongside symptom severity over time, it
may be a marker of mechanisms driving symptom change. We hypothesize that immune marker profiles will
correspond with symptom trajectory over time.
The biological consequences of MST represent a significant health burden for Veterans, especially
women with already higher MST and autoimmunity rates. Understanding the mechanistic link between MST
and peripheral and central inflammation will inform our understanding of immune disruption as a biomarker for
diagnosis, prognosis, and potential treatment targets. Building on the applicant's experience studying immune
signaling and immune contributions to PTSD risk, the proposed training plan will provide the necessary skills to
independently design and implement novel biomarker-guided approaches to improve patients' lives with
neuropsychiatric illness. Completing the proposed research will further support the VA mission towards
developing precision medicine tools for Veteran care in Women's and mental health.

Public health relevance
The proposed CDA- 2 will provide Dr. Friend with the training and support to examine if immune signaling contributes to trauma disorders by analyzing potential blood-based markers of immune function in female Veterans with military sexual trauma (MST) and post-traumatic stress disorder (PTSD). Understanding the mechanistic link between MST and peripheral and central inflammation will inform our understanding of immune disruption as a potential prognostic biomarker. Moreover, biomarkers derived from central nervous system (CNS) extracellular vesicles could allow for less invasive CNS pathology testing in PTSD and other neuropsychiatric conditions. Thus, this proposal aims to support the VA mission of developing precision medicine tools for Veteran care, especially in women’s health and mental health.